Development of High-Speed 3D Super-Resolution Microscope

Project Summary/Abstract Despite a decade of work on super-resolution imaging, a large amount of sub-cellular phenomena remains in- visible due to the poor temporal resolution of current techniques. As a result, there is an urgent need for a ﬂexible, accessible, and quantitative super-resolution imaging system with improved temporal and spatial reso- lution. For example, DNA has characteristic lengths between 5 nm and 150 nm that exhibit signiﬁcant dynamic changes over time scales as small as 1 ms, which are length and time scales that are not within the capabilities of current super-resolution methodologies. Our long-term goal is to develop and apply measurement tools to further our understanding of mechanisms and dysfunction of sub-cellular phenomena. The overall objective of this application and the next step in attaining this long-term goal is to drastically improve the temporal resolu- tion of super-resolution through both single-acquisition super-resolution microscopy as well as 3D localization at an order of magnitude greater ﬂuorophore density. The rationale underlying this research is that current super- resolution instruments are inadequate for visualizing many small-scale and fast sub-cellular processes. Reaching these smaller lengths and faster time scales requires a new approach toward visualizing these phenomena if we are to understand them with sufﬁcient ﬁdelity to treat or diagnose diseases. To ensure that we achieve the ob- jective of this application we have developed the following Speciﬁc Aims: 1) Development of Single-Acquisition Super-Resolution Microscopy, which will result in a 40% improvement in diffraction limited resolution in every im- age, and 2) Development of 3D Dense-Emitter Image Analysis Algorithm, which will result in the ability to either locate in 3D emitters as close together as 60 nm with 10 nm isotropic resolution from a single image or recon- struct the 3D sub-diffraction density of closer emitters. Together these new and improved capabilities will enable improvements to the temporal resolution with which super-resolution data is acquired. The approach is innovative in our opinion, because it utilizes a novel imaging system (Bessel Beam Microscopy) that trades low-frequency information for spatial resolution, which differs from current super-resolution systems that trade temporal reso- lution for spatial resolution. The proposed research is signiﬁcant because it expands super-resolution imaging capability in an area where there is a particularly urgent need. Providing high-speed sub-diffraction limit 3D re- construction capabilities will allow real-time monitoring of, for example, chromatin packing level and stiffness in response to transcription. Additionally, stochastic super-resolution techniques such as STORM/PALM will beneﬁt from the accurate localization at dense labeling, improving their temporal resolution.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will result in an instrument that will expand the measurement capabilities of biomedical investigators as they work to discover and understand the function of the human body and the origins of disease. Thus, the proposed research is relevant to the mission of the NIH to seek fundamental knowledge about the nature and behavior of living systems.